The Influence of Public Health Infrastructure on Prosecutorial Responses to the Opioid Crisis

PROJECT SUMMARY
Through the research and training described in this K01 proposal, the P.I. (Dr. El-Sabawi) will acquire
the necessary skills to become an independent researcher who uses legal epidemiological methods to study
and design evidence-based laws and policies that improve the health of persons who use drugs (PWUD).
Overdose deaths are surging across the U.S., with 40 states reporting increases in mortalities for the 12 month
period ending in May 2022. Some prosecutors have responded to local overdose crises by charging persons
who distribute drugs that cause an overdose death with homicide (drug-induced homicide) (DIH), resulting in
dramatic increases in DIH prosecutions since 2011. Prior research has demonstrated that increased police
activity and enforcement of criminal laws are largely ineffective in decreasing drug use and often lead to poorer
public health outcomes for PWUD. However, the effects of the prosecutorial implementation of DIH laws on
public health remains largely unstudied —equally as unstudied is the relationship between prosecutorial actors
and the local public health and treatment infrastructure. With this 5-year K01, the P.I. aims to examine the
prosecutor’s role in addressing the overdose crisis by focusing on how policy implementation decision-making
is affected by socio-ecological (S.E.) factors, including the presence of other organizations (public health
departments and treatment infrastructure); organizational relationships between the criminal legal, public
health, and treatment systems; and the perceived effect of such prosecutions on drug use and treatment-
seeking behaviors. The P.I. will conduct exploratory semi-structured interviews of prosecutors (AIM 1), local
public health administrators, members of local management entities, defense attorneys, and PWUD (AIM 2) in
North Carolina to capture the S.E. factors present in localities where prosecutors have chosen to pursue DIH
cases versus the factors present in localities where prosecutors have chosen not to pursue such charges.
Using the data gathered in AIMs 1 & 2, the P.I. will develop a Socio-Ecological Model (SEM) of policy
implementation explaining how S.E. factors (including public health and treatment infrastructure) influence the
implementation of DIH laws and how such implementation is perceived to influence the behaviors and
experiences of PWUD (AIM 3). The P.I. will work with an accomplished, multidisciplinary mentorship team (Dr.
Taxman, Dr. Rudes, and Prof. Beletsky) to master four relevant areas of training: (1) policy implementation
science, (2) advanced legal epidemiological evaluation, (3) qualitative interviewing, and (4) implementation
study design. In doing so, this K01 award advances the development of the P.I. as an independent and
productive researcher. The research presented in this K01 award addresses an important public health
concern and has the potential to advance the field by developing a SEM that posits how criminal legal actors
interact with the public health infrastructure in ways that impact the public health of people at risk of overdoses.

Public health relevance
Project Narrative As the overdose crisis continues, some local prosecutors have increased their use of criminal legal penalties to address overdose deaths—despite evidence suggesting that doing so worsens public health outcomes for people who use drugs and their communities. Using a legal epidemiological framework, this study analyzes (1) the factors that influence prosecutors’ decisions to treat an overdose as a murder instead of a public health issue, (2) how such charges impact the health of people at risk of overdose, and (3) how investment in local public health efforts can decrease the involvement of the criminal justice system in addressing overdose deaths.